Efficacy of a culturally-sensitive telehealth platform in fostering community-based care coordination for respectful maternal mental health

Project Summary
The United States spends more money per capita on maternal and child healthcare than any other industrialized
nation, yet maternal and fetal mortality rates are increasing, with non-Hispanic Black women disproportionately
affected. The causes of these disparities are multifactorial, including social determinants of health and
healthcare-related factors. InovCares is a telehealth platform that offers collaborative mobile apps for patient
education, connects patients to culturally sensitive integrated care teams, and promotes the development of
support groups to address the maternal health crisis. InovCares leverages HIPAA compliant NASA-patented
technology and AI videography to deliver personalized primary and specialized care services. The platform offers
video conferencing, phone calls, and text messaging to connect patients to providers, as well as prescription
delivery, and telemonitoring capabilities. The platform has already conducted over 10,000 virtual telehealth
consultations and an initial trial showed significant clinical improvement in symptoms of depression. InovCares
digital health platform provides pregnant women with access to quality medical care and reduces racial
disparities in maternal health. The objective of this STTR Phase I is to evaluate effectiveness of InovCares’
culturally tailored maternal mental health program, which includes cognitive behavioral therapy (CBT),
interpersonal therapy and compassion-focused therapy (CFT) along with peer-to-peer support and gamification
of healthy behavioral changes. AIM 1: Assess the efficacy of the InovCares platform in mitigating stress,
decreasing depressive symptoms, and improving sleep quality among Black expecting mothers, ascertaining the
cumulative impact of optimizing the aforementioned variables on healthy gestational blood pressure. Hypothesis
1: Utilization of the InovCares platform successfully conduces lower stress levels, depressive symptoms, and
improved sleep to 7-8 hours per day, resulting in improved blood pressure readings in Black pregnant women
when controlling for sociodemographic factors, country of origin, age and lifetime traumatic exposure. This will
involve evaluating the efficacy of Health Tribe (peer-to-peer support) participation in combination with receipt of
recommendations based on the Health Risk Report. Successful completion of the Phase I objective will provide
proof-of-concept for the ability of InovCares health assessment tool to identify risk factors to enable behavioral
modifications. Additional development of this technology in Phase II will involve assessing its feasibility to
integrate with teleultrasound for the timely detection of conditions that may compromise fetal health.

Public health relevance
Project Narrative Maternal mortality and morbidity are serious public health concerns in the United States, particularly among non- Hispanic Black women based on the 2021 CDC report that states that a woman’s risk of maternal mortality is 3- 4 times higher if she is black compared to white. Although there are few healthcare systems that facilitate care coordination, they lack maternal telehealth option necessary to optimize access, while others that provide the telehealth option, lack several integrated features such as training the providers for cultural competency, prescription ordering and delivering, tracking, and rewarding healthy life-style changes. InovCares technology plans to use all these integrated features to evaluate the effectiveness of their patented Health-Tribe platform in pregnant women for generating a health assessment report that identifies risks associated and provides guidance for adopting behavioral changes necessary and assessing maternal mental health with care coordination for better maternal outcomes.